Expanding engagement and mentorship of developing scientists through ISDP Annual Meeting participation

The present proposal addresses a critical need to recruit and retain a diverse and
talented pool of scientists, by providing direct travel support to trainees to permit them to
actively participate in the annual meetings of the International Society for Developmental
Psychobiology (ISDP), a well-established, yet exciting and vital, scientific society
devoted to a broad range of scientific questions that cross many levels of analysis. The
mission of ISDP is to promote and encourage research on the development of behavior
in all organisms. The annual meetings feature invited speakers, symposia, oral talks and
posters that span developmental questions across species including humans, with
special attention to the effects of biological factors operating at any level of organization.
Funds from this grant have provided support for pre- and postdoctoral trainees to travel
to these meetings. The present proposal requests 5 years continuation of travel support
from NIH to continue supporting our ability to bring the brightest students and
postdoctoral fellows to this meeting where they will be able to interact with others
examining critical questions related to normal and abnormal development using scientific
paradigms ranging from the molecular to the clinical. Providng multi-year support
encourages a culture of active and continued participation at the ISDP meetings among
graduate students and postdoctoral trainees, prolonging the impact well beyond the
period of support requested.

Public health relevance
The proposal requests funds for travel expenses of graduate students and postdoctoral researchers to attend annual meetings of the International Society for Developmental Psychobiology (ISDP). This addressed the critical need for adequate numbers of highly trained scientists to meet the nation’s biomedical and behavioral research agenda, as well as promoting translational research by emphasizing the integration of basic and clinical research approaches.